AACR Conference on The Science of Health Disparities in Racial/Ethnic Minorities and the Medically Underserved

PROJECT SUMMARY
The proposed conference series, titled “The Science of Cancer Health Disparities in
Racial/Ethnic Minorities and the Medically Underserved,” will be held annually in the fall
(2019-2023). The 2019 conference will be held September 20-23, 2019 in San Francisco,
California. The locations of the 2020-2023 conferences remain to be selected, but will be
chosen based upon the future needs and growth of the conference series. This proposed
conference series will be the 12th-16th in an AACR series focused specifically on the science of
cancer health disparities. The first conference on The Science of Cancer Health Disparities in
Racial/Ethnic Minorities and the Medically Underserved was held in 2007, then annually from
2009-2018. While most conferences on cancer health disparities focus on policy and public
health issues, the goal of this conference is to incorporate perspectives from basic scientists
and clinicians in conjunction with policy and public health. Transdisciplinary interactions
between a variety of disciplines, including basic science, clinical research, population science,
behavioral research, and cancer survivorship, are needed to move the field forward and make
progress in reducing and eliminating disparities as they relate to cancer.
Racial and ethnic disparities in cancer rates are well documented. While data suggest that
differing levels of access to quality care contribute to cancer disparities, other factors also play a
role, including tumor biology, genetics, hormonal status, lifestyle and behavior, screening
policies, comorbidities, environmental exposure and risk, quality of and response to therapy,
and post-therapeutic surveillance. The goal of this conference and the conference series is to
bring together scientists and other professionals working in a variety of disciplines to discuss the
latest findings in the field and to stimulate the development of new research in cancer health
disparities.

Public health relevance
PROJECT NARRATIVE Cancer incidence and death statistics show that certain racial and ethnic groups in the United States suffer disproportionately from cancer and its associated effects. These disparities may be explained by socioeconomic and cultural factors, biological basis, differences in hormonal status and genetic variants, or differences in inherited susceptibilities and molecular pathways for pathogenesis. Over the next 5 years, this conference will continue to bring together basic scientists, physicians, behavioral researchers, population researchers, and other health professionals to foster discussions and collaborations between early-career and senior scientists, moving the field forward, and continue to make progress in reducing and eliminating cancer health disparities.